Harmonizing genomic, transcriptomic, and drug response data across pre-clinical models of cancer to support machine learning approaches for personalized cancer therapy selection

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-OD-
23-082. Machine learning (ML) approaches are showing great promise for predicting therapy responses in large
cancer cell-line pharmacogenomic datasets. However, a large gap still exists between predicting drug response
in cell-lines and the application of ML algorithms in precision oncology settings i.e. for selecting the therapy most
likely to effectively combat an individual patient’s tumor. Currently, effective development of ML algorithms is
hindered by the lack of well-defined, uniform datasets so that competing algorithms can be compared and
performance improvements can be quantified. Furthermore, the data representations used by existing ML
algorithms do not correspond well with the requirements of personalized cancer therapy selection. Just as
importantly, drug response prediction performance in cell-line datasets does not necessarily translate to similar
performance in patient-relevant cancer models or patients. However, there is a noted lack of publicly available
drug response datasets from patient-relevant preclinical models (such as patient-derived xenografts, PDXs; or
patient-derived organoids, PDOs), or indeed, directly from patients, to train and evaluate the algorithms. Finally,
incorporating metadata elements into ML algorithms e.g. those describing the relationships across cancer types
and subtypes, or across the various classes and subclasses of anti-cancer agents can substantially improve
drug response prediction performance, but such annotations have not been applied to key datasets. We propose
to address these challenges by (1) creating an AI/ML-ready, fully harmonized dataset of genomic, transcriptomic,
and drug response data across three distinct cancer models, as well as cancer patients; (2) enriching cancer
drug response datasets via cancer type, cancer therapy, and FDA approval status annotations; (3) packaging
and sharing the cancer drug response datasets as easily digested data structures to serve as inputs to AI/ML
prediction algorithms, partitioned into canonical training and testing subsets; together with scripts for dataset
searching and filtering; and (4) demonstrating the AI/ML-readiness of these unified genomic, transcriptomic, and
drug response datasets via precision therapy response prediction. This proposal will not only integrate publicly
available datasets, but also add unique data from patient-derived models of cancer developed and characterized
with funding from the parent project of this application, i.e. the Cancer Center Support Grant (2P30CA042014)
awarded to the Huntsman Cancer Institute. Our team combines outstanding cancer biology and cancer model
development expertise, computational biology and bioinformatics expertise, and expertise in the development of
computational algorithms for predicting cancer therapy responses; and will generate a powerful, AI/ML-ready
dataset for improving cancer therapy selection algorithms and their application in precision oncology settings.

Public health relevance
PROJECT NARRATIVE Leveraging the genomic, transcriptomic, and functional drug response characterization of patient-derived models of cancer enabled by the parent grant i.e. the Cancer Center Support Grant awarded to the Huntsman Cancer Institute, we will assemble, reprocess, harmonize, and share a rich, pan cancer pharmacogenomic dataset to support the development of AI/ML algorithms for accurate prediction of therapy response in cancer patients. This dataset will facilitate fair performance comparisons across distinct AI/ML drug response prediction algorithms; contain relevant omic and therapy response data for all common cancer model domains as well as patient cancers to make AI/ML predictions relevant for application in precision oncology; and packaged for algorithm developers to easily access and use as input to their AI/ML models.